A deep learning artifact removal method for CPR continuity throughout the shock decision in AEDs

PROJECT SUMMARY
Out-of-hospital cardiac arrest (OHCA) affects more than 475,000 people in the United States each
year. Major determinants of survival from OHCA include continuous high quality
cardiopulmonary resuscitation (CPR) coupled with timely defibrillatory shock, if warranted,
based on accurate shock decisions. According to the American Heart Association (AHA),
delivering continuous CPR along with rapid shock by automated external defibrillator (AED) are
two main interventions that are likely to restart the arrested heart. However, the mechanical
activity of chest compressions during CPR performance induces severe motion artifact in the
electrocardiogram (ECG) signal. Thus, an accurate rhythm analysis and pulse checks require
pauses in chest compressions. Unfortunately, frequent or prolonged interruptions in chest
compressions lead to adverse outcomes after cardiac arrest. Despite previous attempts to work
with CPR-contaminated ECG in AEDs, resuscitation performance has been hampered by two
major factors: 1) there is no AHA-approved validated shock advisory algorithm during CPR
performance, and 2) there is insufficient cardiac arrest data with CPR, which has hampered
advancements using deep learning approaches to remove CPR artifacts. To overcome these
limitations, we propose to develop a database of CPR artifact data already collected from
commercial (Defibtech) defibrillators, and inpatient data from the University of Michigan and
Massachusetts General Hospital. Using this database, we will evaluate and optimize the
performance of our promising CPR artifact removal algorithm based on deep learning. Once the
CPR artifact removal and shockable rhythm detection models are validated, we will integrate our
algorithms into the existing ECG monitoring system at the University of Michigan medical center
and evaluate their performance in real-world scenarios in real time using new CPR data.
Successful completion of our aims will allow continuous evaluation of cardiac rhythms during
AED implementation, reduce interruptions in CPR, and improve clinical outcomes. Additionally,
a large CPR ECG database will catalyze research focused on improving defibrillator performance,
identifying key factors for a successful resuscitation, and reducing morbidity and mortality from
cardiac arrest.

Public health relevance
PROJECT NARRATIVE Out-of-hospital cardiac arrest (OHCA) affects more than 475,000 people in the United States each year. Major determinants of survival from OHCA include continuous high quality cardiopulmonary resuscitation (CPR) coupled with timely defibrillatory shock, if warranted, based on accurate shock decisions. Since CPR introduces severe motion artifacts into the ECG, automated external defibrillators require cessation of CPR for up to 20 seconds to determine whether an arrhythmia is shockable or non-shockable. The current work proposes to remove CPR artifacts in near real-time without CPR stoppage so that accurate shock decisions can be made.